Functional interrogation of parasitic flatworm TRPM channels to identify novel anthelmintics

PROJECT SUMMARY
Praziquantel (PZQ), a drug used clinically for four decades, is essential for treatment of many neglected
tropical parasitic diseases; PZQ is the key therapy for treating schistosomiasis, a disease that afflicts over 200
million people worldwide and it is classified as an essential medication by the World Health Organization.
However, heavy reliance on PZQ has several limitations. One challenge has been the lack of understanding of
how PZQ works, as no molecular target in parasites has been identified. Additionally, sensitivity of parasitic
flatworms to PZQ varies, leading to different clinical dosages being required for treating different infections.
Infections caused by pseudophyllidean cestodes, the causative agents of long lasting, sometimes fatal
diseases such as sparganosis (Spirometra spp. and Sparganum spp.) and diphyllobothriasis (Diphyllobothrium
spp.) currently lack an effective drug treatment.
My sponsor's laboratory (Dr. Marchant) recently identified a target for PZQ in parasitic flatworms: a Ca2+
permeable ion channel in the transient receptor potential melastatin family (TRPMPZQ). Resolution of this target
provided an explanation for the different sensitivity of parasites to PZQ, as the binding pockets of TRPMPZQ in
tapeworms with low sensitivity to PZQ contain two key natural amino acid variants that differ from the
schistosome TRPMPZQ pocket. I hypothesize that these differences underlie the decreased sensitivity of these
tapeworms to PZQ. In Aim 1, I will functionally profile cestode TRPMPZQ channels with the goal of discovering
novel chemotypes that activate TRPMPZQ in parasite species that show poor sensitivity to PZQ. This Aim will
provide me training in cell culture, molecular cloning, fluorescence reporter methods and experience
developing a robust, reproducible drug screening pipeline. This effort will also be the first study of a tapeworm
ion channel by high-throughput drug screening. Next, building on my progress evidencing the druggability of
this family of ion channels, I propose in Aim 2 to identify and functionally profile other TRPM paralogs in
schistosomes in vitro and by functional genetic manipulation in the parasites themselves. The work will utilize a
broad range of experimental methods important for my training, including bioinformatic analysis, generation of
stable cell lines, and methods to localize and manipulate gene products within parasites. This work will likely
generate new tools useful for the broader molecular parasitological community.
Overall my training plan will help me master skillsets to work with parasitic flatworms and manipulate their gene
products in vitro (Aim 1) and ex vivo (Aim 2). My training and mentoring plan would provide opportunities for
participation at conferences and enrollment in courses on parasitology, drug design, and global health,
equipping me with skills to work towards a career focused on efforts to eradication neglected tropical diseases.

Public health relevance
PROJECT NARRATIVE Human diseases caused by parasitic flatworms afflict millions of people worldwide and cause significant healthcare burdens in many countries. The current clinical therapy relies on a single drug (praziquantel, PZQ) for which the parasitic target was only recently discovered – a transient receptor potential ion channel activated by PZQ (TRPMPZQ). My proposal builds from our discovery of TRPMPZQ to develop new and improved therapies for neglected tropical diseases caused by tapeworms (cestodes) and blood flukes (schistosomes).